Store-operated Orai3 calcium channels in metabolism and obesity

Project Summary/Abstract
This K99/R00 proposal aims to characterize novel molecular mechanisms of obesity and
develop non-invasive methods for treating obesity and obesity-related cardiovascular diseases. The
proposal addresses a fundamental gap in knowledge with a significant impact on the treatment of
obesity. Obesity is a major contributor to several pathologies, including type 2 diabetes, cardiovascular
disease, and cancer. In recent years, studies have shown that Ca2+ signals play a crucial role in lipid
metabolism. Orai proteins (Orai1-3) are highly Ca2+ selective channels that contribute ubiquitous and
evolutionary conserved routes of regulated Ca2+ entry into all cells and play a major role in a myriad of
cellular and physiological functions, including lipolysis. Here, I propose to study the function of Ca2+
entry through Orai3, a mammalian specific Ca2+ selective Orai channel protein, in metabolism, neuronal
innervation, neuronal activation, and its role in regulating thermogenesis and obesity. We have
generated Orai3 whole-body knockout and Orai3flx/flx mice for tissue-specific knockouts. My preliminary
data show that Orai3 knockout mice housed at 15-18°C and on regular diets quickly become obese,
and their weight gain is derived from fat accumulation. This suggests that Orai3 plays an essential role
in fat metabolism. These Orai3 KO mice also have reduced heat generation, reduced sympathetic
innervation to brown adipose tissue (BAT), suggesting that adiposity is due to reduced BAT
thermogenesis and/or altered innervation or activation of norepinephrine (NE) producing sympathetic
neurons, which regulate BAT thermogenesis. In this application, I propose to address the above-
described causes of adiposity in Orai3 KO mice with the following three aims and key experiments, 1)
Ca2+ entry through Orai3 is crucial for BAT mitochondrial heat generation to control adiposity, which
will be determined by measuring parameters of mitochondrial metabolism. 2) Orai3 activity is critical for
Ca2+-dependent gene transcription of UCP1, required for BAT thermogenesis, which will be assessed
by studying the transcription factors that regulate UCP1 expression and by rescuing UCP1 expression
in Orai3 KO mice and determining cardio-metabolism on Orai3 KO and UCP1-rescued mice. 3) Orai3
is required in the central and peripheral nervous system (CNS and PNS) to regulate BAT activity, which
will be determined by analyzing Orai3 levels in both CNS and PNS using RNA scope, deleting Orai3 in
CNS and measuring BAT activity, and deleting Orai3 in CNS and measuring cold and high fat diet-
induced hypertension and obesity. This study will help decipher the unique role of Orai3 in BAT and in
both central and sympathetic neurons. It will bridge the gap between Ca2+ homeostasis and
mitochondrial function and unveil a novel role for Orai3 Ca2+ signaling in lipid metabolism and obesity,
establishing Orai3 as a target in obesity and obesity-related cardiovascular disease.

Public health relevance
Project Narrative Obesity has taken epidemic proportions worldwide, with as many as 60-70% of the US population considered obese. Obesity enhances susceptibility to life-threatening diseases such as heart disease, type 2 diabetes, and cancer, and current treatment modalities of obesity are ineffective. This study aims to establish the previously unknown pathway of Ca2+ entry through Orai3 channels in brown adipose tissue and sympathetic neurons as a major regulator of brown adipose tissue thermogenesis and obesity. Findings from this work will shed light on the molecular mechanisms that regulate obesity and will thus help in developing new non-invasive methods for the treatment of obesity.